Core:1 Biological Testing

Core 1 will focus on the biological evaluation of anticancer natural products that are identified from complex
extracts, and after subsequent isolation, confirmed to be the active constituent. This strategy, called bioassay-guided
isolation, facilitates the identification of biological activity within complex mixtures from plants, fungi, and
cyanobacteria. Extracts and compounds that display cytotoxicity and modulation of autophagy will be prioritized
based on high-content phenotypic screening and the ability to inhibit 3D spheroid growth by Core 1. Hits will be
further purified by Projects 1-3 (OSU, UIC, and UNCG, respectively) and the purified fractions interrogated until
pure compounds emerge. Promising pure compounds will ultimately be evaluated in animal models to assess
efficacy and toxicity. Core 1 will work closely with Core 2, led by Dr. Fuchs, to evaluate structure-activity
relationships and to establish optimal formulation strategies and determine pharmacokinetics profiles prior to in
vivo testing in Core 1. This approach will help maximize the possibility of successful animal experiments based
on dose and route of administration. Mechanism of action studies will be conducted to find protein interacting
partners and pathways based on transcriptomics. Dr. Burdette of Core 1 and her Co-Investigator, Dr. Aldrich,
have well-established collaborations with all of the Project Leaders and this application includes preliminary data
indicating our ability to successfully integrate compounds from all of the projects and cores. In Aim 1, we will
evaluate all extracts and compounds using a cytotoxicity and autophagy high throughput screen. In Aim 2, we
will prioritize compounds using a high content molecular fingerprinting assay to evaluate whether compounds
likely have unique mechanisms of action as compared to standard chemotherapies used as controls. We will
also determine the potency of compounds against 3D spheroids, which typically helps to identify lead compounds
that have potency in vivo. The prioritized compounds will be evaluated in vivo in both a human OVCAR8-RFP
xenograft in athymic nude mice and using a newly developed syngeneic model with an intact immune system.
Finally, in vivo active compounds will be optimized in collaboration with Core 2 to develop more active synthetic
analogues and to develop photo-affinity probes and RNA sequencing for target and pathway identification.
Overall, Core 1 tests all compounds from the Projects as well as those made in Core 2 for in vitro and in vivo
activity. Data are then integrated fully with Core A for biostatistical analysis.

Public health relevance
The overarching goal of this Program Project is to isolate novel agents from natural sources for the treatment of cancer. The role of Core 1 is to provide biological testing using a variety of molecular, cellular and animal-based systems to identify promising leads for further development. Core 1 will obtain materials for testing from each of Projects 1-3, work with Core A on biostatistical analysis, and identify leads that Core 2 can modify synthetically to enhance activity and investigate for pharmacokinetic and other parameters as candidate drug leads.